Impact of Government Nutrition Benefit Program Participation on Children's Health and Healthcare Utilization

PROJECT SUMMARY/ABSTRACT
Food insecurity (FI) affects almost 18 million children across the United States, placing them at
increased risk of adverse health outcomes including poor physical and mental health, behavioral problems,
and developmental delay. Children experiencing FI are also less likely to access preventive care and
experience increased rates of delayed medical care due to cost and increased emergency department (ED)
utilization. FI disproportionately impacts Black and Hispanic children and children from immigrant families and
can therefore exacerbate existing disparities in these children's health and healthcare utilization. Childhood FI
therefore represents an important priority for health systems, payers, and policymakers seeking to increase
access to care, improve outcomes, and reduce avoidable healthcare utilization and costs. Government
nutrition benefit programs, such as WIC and SNAP, are key sources of nutritional support for families with FI.
Participation in these programs has proven health benefits, including decreased rates of preterm birth and low
birthweight among infants, and improved diet quality and reduced FI among children. However, only 50% of
eligible women and children currently receive WIC, and only 75-85% of eligible households receive SNAP.
Healthcare providers and health systems could therefore mitigate the negative health impacts of childhood FI
by identifying families who are eligible for, but not enrolled in, WIC or SNAP and providing them with
enrollment assistance. Enrollment assistance interventions have the potential to both enhance health and
social service integration and generate cross-sector cost savings for payers and health systems. In order to
inform the design and implementation of novel, effective enrollment assistance interventions, there is a critical
need to (1) characterize the impact of WIC and SNAP participation on children's overall health and access to
healthcare, (2) characterize healthcare utilization patterns and healthcare expenditures for children who are
eligible for, but not receiving, WIC and SNAP benefits, in order to determine where enrollment interventions
should focus and estimate potential cost savings associated with increasing enrollment, and (3) develop family-
centered strategies for providing WIC and SNAP enrollment assistance in healthcare settings. The specific
aims of this application are: (1a) to examine associations between WIC and SNAP participation and caregiver-
reported child health and access to care, (1b) to examine the association between WIC and SNAP participation
and healthcare utilization and expenditures, and (2) to explore food insecure families' perceived determinants
of government benefits enrollment and their revealed preferences for health-system based benefits enrollment
support.

Public health relevance
PROJECT NARRATIVE Food insecurity (FI) affects almost 18 million children across the United States, placing them at increased risk of adverse health outcomes including poor physical and mental health, behavioral problems, and developmental delay. The WIC and SNAP programs provide essential nutritional support for families with FI and have proven health benefits, but only 50% of eligible families receive WIC, and only 75-85% of eligible households receive SNAP. Health systems could therefore mitigate the adverse health impacts of FI, enhance health and social service integration, and generate cross-sector cost savings by providing food insecure families with benefits enrollment assistance in clinical settings.